Highly Multiplexed Cell-Based GPCR Assay.

Project Summary/Abstract
Chip-based technologies - e.g. DNA microarrays and next generation sequencing - have
profoundly accelerated the pace of biomedical discovery because they are miniaturized,
multiplexed, and highly scalable. We will bring these same virtues to cell-based
screening against GPCRs, the most prevalent targets of therapeutic drugs to treat mental
illness and other diseases and conditions, by applying SpectraGenetics' FAP technology
to printed reverse transfection microarrays.
The new assay system will detect and quantify the responses of many GPCRs in parallel
by interrogating arrayed reverse-transfected mammalian cells that express FAP-tagged
receptors. This miniaturized, multiplexed and scalable system will enable diverse GPCR
discovery projects, and will dramatically lower the cost-per-target in primary and
secondary drug screens, thereby relieving major bottlenecks in the development of new
therapeutic molecules.

Public health relevance
Project Narrative. Our goal is to develop and commercialize an automated system that interrogates microarrays of reverse-transfected mammalian cells to detect and quantify GPCR responses to agonists, inverse agonists, and other classes of ligand. By enabling screening against large numbers of human GPCRs in parallel, the system will dramatically expand the scope of GPCR drug discovery and development projects without expanding their costs, and thus lead to new therapeutic treatments for neurological and mental diseases and conditions.